Development and Feasibility Trial of Online Peer Support for Parents of At Risk Youth

ABSTRACT
At risk youth (ARY) are those who are at risk for suicide and self-harm. Suicide is the second highest cause of death among adolescents, but parent support and communication can improve mental health outcomes for this population. There are few formal support programs to help parents navigate conversations with their children about suicide and self-harm. This K23 project will: 1) survey a cross-section of parents of ARY in the United States to better understand their experiences, 2) design a stakeholder-informed online support intervention including peer support, and 3) pilot test the online support intervention for feasibility and acceptability. Conduct of these aims, in addition to a career development plan inclusive of coursework, workshops, and leadership development, will allow for the applicant’s academic growth in nationally representative surveys, stakeholder-engaged intervention development, clinical trials, and research program leadership, and will further advance the applicant’s transition to independence. These aims will also provide the necessary data to conduct a future R01 randomized control trial to evaluate the effectiveness of the stakeholder-designed intervention to improve parent confidence in supporting ARY.

TITLE
Development and Feasibility Trial of Online Peer Support for Parents of At Risk Youth

MAJOR GOALS OF THE PROJECT

Aim 1: Identify factors associated with supporting youth in a national sample of parents.
Identifying parent factors associated with supporting youth is critical to design parent support interventions that are feasible and effective at increasing parent support and improving youth health. I will conduct an online, national, cross-sectional study of parents of ARY to identify factors associated with parent support.

Aim 2: Develop a stakeholder-informed online support intervention for parents of ARY.
Stakeholder input is vital for creating an acceptable support intervention to help parents support their children and improve health outcomes for ARY. Using a community engaged intervention mapping approach, I will continue to conduct semi-structured individual interviews of up to 40 parents to understand key stakeholder perspectives on the core features and design of an online parent support intervention. An iterative user-centered design process will be used to develop the intervention currently planned to consist of a 1:1 peer network.

Aim 3: Assess feasibility and acceptability of the intervention with parents of ARY.
Parents of ARY seek support and resources online and assessing feasibility and acceptability of an online support intervention for these parents is needed before further exploration of intervention effects. I will pilot the stakeholder-informed intervention in a randomized feasibility trial with parent-ARY youth dyads to assess their perspectives regarding its feasibility and acceptability compared to control dyads accessing an existing online information page for families of ARY. I will use the RE-AIM Framework to assess usability and acceptability of the intervention and website through qualitative and quantitative assessments.

CURRENT MENTORING TEAM QUALIFICATIONS
Primary Mentor Dr. Alfgeir Kristjansson has extensive experience in adolescent suicide risk assessment and prevention through his youth behavioral development work both in the United States through the West Virginia Prevention Research Center and in Iceland through his development of the Icelandic Prevention Model. Co-Mentors Dr. Nadia Dowshen and Elizabeth Miller have expertise in adolescent development and mental health as both adolescent medicine specialists and researchers. Dr. Dowshen’s research has included suicidality assessments and the development of support interventions specific to adolescents and young adults. Dr. Miller’s research has included mental health assessments and intervention development including supporting youth with suicidal ideation. This includes involvement in the World Mental Health Consortium.

NEW CONSULTANT
Dr. Stephen Deci is a board-certified child and adolescent psychiatrist and the Interim Division Chief of the Child & Adolescent Division in the Department of Behavioral Medicine at the West Virginia University School of Medicine. Dr. Deci’s clinical expertise is in adolescent suicide prevention and he is the Medical Director of the Adolescent Inpatient Mental Health Unit in the Chestnut Ridge Psychiatric Hospital where he cares for adolescents who considered or who have attempted suicide. He has extensive connections to patients and families impacted by suicide and self-harm and will ensure I am well connected to these communities.

Public health relevance
PROJECT NARRATIVE At risk youth (ARY) are those who are at risk of suicide and self-harm with suicide being the second highest cause of death in adolescents. Little is known about the experiences and needs of parents of this population of vulnerable youth. Parent support is recognized as an important factor in protecting ARY from self-harm and suicide, but there are few evidence-based support programs for parents of ARY. This study will survey a cross-section of parents about their experiences and will develop an online intervention that connects them with other parents for mentored peer support. By assessing feasibility and acceptability of the new parent support intervention, this work will inform future research aimed at improving health outcomes for ARY.